Administrative Core

Abstract
The Administrative Core (Admin Core) will be established as an integrated, priority-setting consortium
involving the Principal Investigator (PI/PD), an internal CETR leadership team, and a Scientific Advisory
Committee (SAC) with programmatic involvement from NIAID to enhance potential product outcome. The
management function is designed to provide administrative support that facilitates the success of individual
Projects, promotes effective integration and allocation of support functions and resources, and stimulates
scientific exchange between CETR members, thus ensuring that the overall CETR program achieves its
objectives. The Admin Core will be overseen by the Center PI, Dr. David Perlin, who will be supported by a
seasoned administrator and financial director to coordinate and manage all administrative functions. To best
advance CETR objectives, the Admin Core will coordinate regular meetings of Project Leaders and their
collaborators (and subcontractors), scientific/discovery Core Directors, and SAC members. The meetings are
designed to advance compounds through the discovery matrix enabling timely and objective “go, no-go”
decision making. The Admin Core will also facilitate an annual review meeting with the SAC, and reverse site
visit at NIAID. It will produce and submit the annual progress report to the NIH, and it will coordinate research
publications, meeting presentations, reports and press releases. Finally, it will be the liaison with the Patent
and Licensing group for the protection of intellectual property generated by the CETR, as well as licensing
opportunities. The Admin Core will execute the following Specific Aims: 1) establish a highly efficient
management structure that provides essential oversight and guidance for Project Leaders and Core Directors,
effectively integrates the Scientific Advisory Committee as strategic advisors in the discovery/development
process, and promotes scientific exchange; 2) maximize allocation of resources and prioritize compound
development by establishing critical metrics for “go, no-go” decision making and resource allocations by
supporting close interactions of Project Leaders and Core Directors and scheduling regular reviews; 3) develop
an effective strategy to assess year-end Project performance, prepare interim and year-end reports, and recruit
a Supplemental project, as appropriate; 4) coordinate publications, presentations of results, and press releases
arising from the output of these studies; and 5) establish an internal organizational structure that addresses
logistics for material transfer agreements, confidentiality, intellectual property filings and licensing opportunities
and negotiations; and develop a managerial plan for conflict resolution and other operational issues.